Endocannabinoid Metabolism in Acute Pain

Project Summary
Failure to adequately treat pain accounts for hundreds of billions of dollars of lost productivity and medical
expenses annually. According to the Centers for Disease Control, each day in the United States over forty people
die from an overdose of prescription pain killers (e.g. Vicodin and OxyContin). Consequently, there is an urgent
need to develop new, safe, and potent non-opioid analgesics for the treatment of acute and chronic pain. Many
surgical procedures induce significant acute pain that is difficult to treat. Patients who undergo such major
surgical procedures are also at an increased risk of developing a subsequent opioid addiction. Therefore,
improving acute pain control will not only enhance patient outcomes but may also lead to reduced prevalence of
subsequent opioid abuse. The endocannabinoid 2-arachidonoylglycerol (2-AG) produces analgesia by activating
cannabinoid receptors. However, 2-AG can also be hydrolyzed by the enzyme monoacylglycerol lipase (MAGL)
to generate arachidonic acid, the precursor to downstream eicosanoids that can promote pain. In a recent
publication, our group demonstrated that 2-AG levels were elevated in patients who developed greater acute
postoperative pain, suggesting that 2-AG/eicosanoid crosstalk may directly modulate acute pain in humans.
However, the contribution of 2-AG metabolism toward acute pain is poorly defined and its role in eicosanoid
biosynthesis and pain in humans is lacking, highlighting a major gap in our understanding of endocannabinoid
metabolism and pain. The current proposal leverages rodent surgical models and patient derived samples to test
the major hypothesis that MAGL activity is essential for the biosynthesis of cyclooxygenase and 5-lipoxygenase
(5-LOX) derived eicosanoids, which we hypothesize operate in parallel to promote acute pain. In Aim 1, we will
employ complementary pharmacological and genetic approaches to test the hypothesis that MAGL inhibition
suppresses acute pain by depriving cyclooxygenase and 5-LOX enzymes of arachidonic acid for eicosanoid
biosynthesis within the incision site. This aim will also employ selective inhibitors and 5-LOX KO mice to test the
hypothesis that 5-LOX inhibition attenuates acute pain. Aim 2 will leverage novel conditional MAGL knockout
mice to identify peripheral cell populations wherein MAGL activity contributes to postoperative eicosanoid
biosynthesis and pain. Aim 3 will characterize 2-AG/eicosanoid crosstalk in perioperative human tissue and will
assess the contribution of 2-AG and eicosanoid levels toward acute pain in humans. The outcome of this study
will provide fundamental insights into endocannabinoid/eicosanoid crosstalk and may identify MAGL as a novel
target for the treatment of acute pain, thereby providing the foundation for the rapid translation of MAGL inhibitors
to patients suffering from inadequately controlled pain.

Public health relevance
Project Narrative Acute pain accompanies invasive surgical procedures and is often difficult to control, despite the use of analgesics such as morphine and cyclooxygenase inhibitors. Moreover, opioids present additional risks to surgical patients that cause complications, delay discharge, and can lead to addiction. This proposal will characterize the contribution of endocannabinoid metabolism toward postoperative pain and may lead to the development of novel opioid sparing analgesics.